Research Development Core

ABSTRACT
The Research Development Core (RDC) is an integrated platform that provides access to the USC-Buck NSC
Resource Cores (RCs) and represents an innovative approach to advance geroscience training and mentoring,
primarily to junior faculty and new investigators especially from institutions that lack aging programs. The RDC
will employ three primary mechanisms to achieve this goal: the first is to provide access to USC and Buck
Institute expertise and technologies by funding and innovative research in aging sabbaticals scheme. We will
also provide funding for innovative pilot projects and vouchers to ensure that the NSC course will used by
investigators from across the country, especially those new to aging field. The proposed USC-Buck NSC
Research Development Core (RDC) is significant because it will advance the science of aging, provide much-
needed training and professional development of early career scientists, provide access to technology
platforms and promote the aging field beyond its current boundaries.